Preventing speech and language disorders in infants with classic galactosemia

Project Summary/Abstract
This study investigates whether early, proactive intervention improves speech and language outcomes in
infants at risk for communication disorders. Speech and language disorders are common and inflict high social,
emotional, and educational burdens. Preventive treatments are not available; assessments and treatment are
usually not initiated until ages 2 or 3 years when deficits manifest. Infants with classic galactosemia (CG) hold
the key towards investigating proactive approaches because they are at high risk not only for motor and
cognitive deficits but also for severe speech and language disorders. Because CG is diagnosed via newborn
screening, the known risk can be leveraged to evaluate whether proactively supporting the acquisition of
prespeech (2 to 12 months; cooing, babble) and early speech (12 to 24 months; first words, speech sound
acquisition, vocabulary growth, sentence complexity) can reduce the communication deficits associated with
CG. We designed and launched a proactive speech/language program called Babble Boot Camp (BBC) for
infants with CG, ages 2 to 24 months. Initial results are consistent with a beneficial effect on speech and
language development, but generalizing from a small pilot cohort is impossible. The proposed study enhances
the power, scope, and impact of the BBC by implementing it in a larger CG cohort and evaluating it against
control cohorts with and without CG. A pediatric speech-language pathologist implements the program via
parent training. Parents learn about the typical milestones of prespeech, speech, and language development,
potential red flags for delays, and importantly, activities and routines that support typical development for all
stages of the program, for instance stimulating and reinforcing babble, shaping first words, and building
vocabulary and sentence complexity. Longitudinal measures of coo, babble, speech, language, and linguistic
environment using automatized daylong audio recordings in conjunction with signal processing software
generate a rich, objective data matrix. To quantify indirect treatment effects, measures of cognition and quality
of life are also collected. Formal testing of speech, language, cognition, and quality of life outcomes is
performed at 24 months, with follow-up at 36 and 48 months. Using multilevel growth curve models, direct
(speech, language) and indirect (cognition, quality of life) treatment effects will be evaluated longitudinally and
through group comparisons in the three cohorts. Expected results will show that proactive services improve
speech and language outcomes, providing objective evidence to change clinical management from deficit-
based to proactive services. Indirect benefits for cognition and quality of life are possible. Results will motivate
testing proactive approaches in infants with other risk types for speech and language disorders. This study has
potential to enhance health and reduce disease burden associated with speech and language disorders. It fits
a high NIH funding priority by developing and implementing treatment for intellectual and developmental
disorders with the potential of improving quality of life and cognitive and behavioral manifestations.

Public health relevance
Narrative Children with classic galactosemia are at high risk for severe speech and language disorders and typically start receiving lengthy courses of therapy at ages 2 to 3 years, only after communication difficulties have become evident. Because classic galactosemia is diagnosed via newborn screening, the risks for the communication disorders are known at birth, motivating this study evaluating whether a bundle of preventive speech and language services (“Babble Boot Camp”) during the first two years of life leads to improved speech, language, and quality of life outcomes. If results confirm initial pilot results showing that these earliest prevention measures are more effective than traditional therapy later on, this will profoundly change how infants with galactosemia receive help learning to talk, and it will motivate similar studies in infants with other types of risks for speech and language disorders.